Repurposing human kinase inhibitor chemotypes for Neglected Tropical Diseases

SUMMARY/ABSTRACT
Human African trypanosomiasis (HAT) and Chagas disease (CD) are neglected tropical diseases
(NTDs). Current drugs show increasing numbers of treatment failure, low efficacy, difficult treatment regimens
or severe side effects. In a unique industrial-academic collaboration, the PIs, in collaboration with GSK, ran a
high-throughput screen (HTS) of ~46,000 kinase-targeted inhibitors against Trypanosoma brucei, the causative
agent of HAT. This resulted in the discovery of 797 potent (T brucei EC50<1 μM; pEC50 6) and selective hits
(>100-fold over HepG2 cells) that were sorted into 59 structural clusters, plus 53 singletons. 14 chemotypes
including 13 clusters and 1 singleton have been explored for their structure-activity and structure-property
relationships. A “parasite-hopping” approach has identified six of these with interesting activity against T cruzi
(CD).
This competitive renewal outlines a hit-to-lead medicinal chemistry program that will continue to optimize
high-priority hit clusters from the original HTS. These have been identified through re-analysis of the original
HTS data to place an emphasis on compounds that are cidal and predicted to cross the blood-brain barrier (BBB)
which is essential to treat stage 2 of HAT. Additionally, we will employ computer-aided drug discovery to further
explore those chemotypes for which we have identified a putative target. We will also perform hit-to-lead
medicinal chemistry optimization on the six chemotypes that have been identified as of interest for T cruzi. We
will also look for synergistic effects between clusters that have complementary activity profiles (e.g. slow acting,
cidal in nature, and fast acting, static in nature) and in combination with standard trypanocidal drugs.
Optimization will result in the delivery of high-quality lead compounds from each of these chemical
classes, and the lead compounds will meet stringent profiles of cellular potency and selectivity, BBB permeability,
physicochemical and metabolic properties, and pharmacokinetic properties in mice depending on the disease
targeted. Furthermore, these lead series will display in vivo efficacy in the murine models of disease.
The optimization program will be performed under the continuing collaboration between NEU and CSIC, with
critical contributions of expertise in drug metabolism and physicochemical properties experiments from
AstraZeneca and UCSD. We have developed and implemented a testing funnel that ensures that the
optimization process will address the most critical lead criteria. Finally, we will perform the target identification
and mode of action studies by different approaches including chemical proteomics, induction of resistance and
whole genome sequencing and metabolic fingerprinting.
This project will deliver (a) multiple lead compounds for HAT and CD that meet well-defined Lead Criteria;
(b) broader profiling of lead compounds against more stringent Candidate Criteria; (c) identification of target for
lead series or compound. In this way, we intend to help fill the pre-clinical candidate pipeline for HAT and CD.

Public health relevance
NARRATIVE Human African trypanosomiasis and Chagas disease are classed as neglected tropical diseases by the World Health Organization. They suffer from a lack of financial investment from the for-profit pharmaceutical industry, yet current treatments are associated with limited efficacy, increasing instances of treatment failure, high cost and long-term toxicity issues. This project will focus on the development of compounds that meet the Target Product Profiles for the respective disease with the view of obtaining pre-clinical candidates and understanding the mode of action and/or identifying the target of lead series.